Spatial Control of Myeloid Differentiation

Abstract:
Mounting evidence indicates that lineage decisions are controlled by local structures that support differentiation
in distinct regions of the bone marrow. Our ability to manipulate hematopoiesis to treat disease has been
hampered by our lack of understanding of these anatomical cues.
We have found that HPC are regionally organized in the BM and that progenitors and immature cells belonging
to the same lineage segregate to different sinusoids. We have also found that there is regional organization to
CSF1 production and that specific BM vessels are critical sources of CSF1 that regulate MDP, monocytes and
dendritic cells but not HSC or macrophages. The central hypothesis is that different subsets of sinusoids
function as assembly lines or hubs that organize and maintain different hematopoietic lineages through the
production of lineage-specific cytokines. We want to understand how these cellular assembly lines function in
the steady-state and after perturbation by acute myeloid leukemia (AML).
We will test this hypothesis in two aims. In Aim 1 we will determine the physiology of these assembly lines
using clonal fate mapping in situ; identifying the components of each assembly line; and conditionally deleting
specific cytokines from key components of each assembly line. In Aim 2 we will investigate how AML inhibits
normal hematopoiesis by perturbing the microenvironment that supports each assembly line.

Public health relevance
Narrative: Using in vivo models of myelopoiesis the studies will define the molecular and cellular mechanisms through which different bone marrow vessels control myelo and erythropoiesis. Identification of the mechanisms used by specific vessels to regionally organize the bone marrow, provide spatiotemporal control of HPC differentiation; and the determination of how leukemia perturbs these structures to inhibit normal hematopoiesis is expected to result in the identification of novel targets and strategies for therapeutic intervention